Hepcidin therapy for iron overload and hematologic disorders

DESCRIPTION (provided by applicant): Iron overload is the main cause of morbidity and mortality in hereditary hemochromatosis, 2-thalassemia and various anemias that require chronic transfusions. Alternatives to current treatments of iron overload are a high priority, as reflected in a recent NIH initiative (PAS-10-046). Hepcidin deficiency is the direct cause of iron overload in nearly all cases of hereditary hemochromatosis and in β-thalassemia intermedia, and may contribute to iron overload and maldistribution in β-thalassemia major. Hepcidin therapy is a rational experimental approach to the prevention and treatment of iron overload in these disorders. Natural hepcidin is expensive, rapidly cleared from circulation and not orally absorbable. We developed 7-9 amino acid peptides, minihepcidins that mimic the activity of hepcidin and exceed its potency. Some have been engineered for oral absorption, and have shown considerable activity by oral route in mice. We will determine the potential of minihepcidins to prevent iron overload or reverse its toxic effects in hemochromatosis and β-thalassemia, and examine the effects of hepcidin agonists on β-thalassemic erythropoiesis in mouse models and in bone marrow cultures and identify those mechanisms that could ameliorate anemia. Specifically, we will: 1. Select a parenteral and an oral minihepcidin for subsequent studies based on the dose-response relationship and duration of hypoferremic effect in C57BL/6 mice and hepcidin knockout mice. 2. Define the effects of minihepcidins in animal models of hereditary hemochromatosis. a. Can minihepcidins started after weaning prevent the development of iron overload in mouse models of severe (hepcidin knockout) or moderate (HFE knockout) hereditary hemochromatosis? b. Can minihepcidin treatment of mice with established iron overload (hepcidin or HFE knockouts) redistribute iron away from vulnerable cells and tissues (hepatocytes, pancreatic islet cells, cardiomyocytes) to relatively iron-resistant macrophages? c. Can minihepcidins reverse iron overload-related liver damage in the gerbil model of iron-induced hepatic cirrhosis? 3. Define the effects of minihepcidins in animal models of β-thalassemia. a. Can minihepcidins prevent iron overload in a mouse model of β-thalassemia intermedia, while improving (or not worsening) anemia? b. Can minihepcidins ameliorate iron overload in transfused mice with β-thalassemia major and redistribute iron to less vulnerable locations, without worsening anemia? c. Identify mechanisms by which minihepcidins can improve β-thalassemic erythropoiesis. This project would establish minihepcidins as viable drug leads for further development, and would eventually help patients with iron overload disorders by providing them with improved therapeutic options.

Public health relevance
PUBLIC HEALTH RELEVANCE: Iron overload diseases are an important medical problem in need of new treatments. Building on recent advances in the understanding of iron metabolism, we propose to develop and test new kinds of medications for the treatment of iron overload in hereditary hemochromatosis and Cooley's anemia. Project Narrative Iron overload diseases are an important medical problem in need of new treatments. Building on recent advances in the understanding of iron metabolism, we propose to develop and test new kinds of medications for the treatment of iron overload in hereditary hemochromatosis and Cooley's anemia. __SpecificAimsTextDelimiter__ Hepcidin therapy for iron overload and hematologic disorders This translational preclinical proposal explores the use of novel parenteral or oral hepcidin agonists for the treatment of iron overload disorders. Successful completion of this study would establish hepcidin agonists as viable drug candidates for these conditions. Iron overload is a principal cause of morbidity and mortality in hereditary hemochromatosis, β-thalassemia with or without transfusion dependence, congenital dyserythropoietic anemias and various anemias that require chronic transfusion support. Alternatives to current treatments of iron overload are a high priority, as reflected in a recent NIH initiative (PAS-10- 046, Stimulating Hematology Investigation: New Endeavors (SHINE) (R01)). Iron overload is one of the five targets of this Program Announcement. Hepcidin deficiency is the direct cause of iron overload in nearly all cases of hereditary hemochromatosis and in β-thalassemia intermedia, and relative hepcidin deficiency may contribute to iron overload and maldistribution in β-thalassemia major. Hepcidin therapy is therefore a rational experimental approach to the prevention and treatment of iron overload in these disorders. Natural 25 amino acid hepcidin is a 4-disulfide peptide that is expensive to produce, is rapidly cleared from circulation and is not orally absorbable. Under separate funding, we used structure-function analysis of the hepcidin-ferroportin interaction to develop a series of 7-9 amino acid peptides, "minihepcidins" that mimic the activity of hepcidin and already exceed its potency in cell-based bioassays and in mice. Some of these peptides have been engineered for oral absorption, and have shown considerable activity in mice when given by gavage. The optimization of minihepcidins is ongoing but sufficient potency has already been achieved to begin testing in animal models of disease. The potential benefits of hepcidin therapy are already supported by "proof of concept" studies using mouse models of hemochromatosis and β-thalassemia which were genetically altered to overexpress hepcidin. However, these studies could not explore the feasibility of using hepcidin or its agonists as drugs, including dose-response relationships, basic pharmacodynamics and major toxicities of hepcidin therapy. Using more realistic drug delivery models, we will determine the potential of hepcidin agonists to prevent iron overload or reverse its toxic effects in hemochromatosis and β-thalassemia. Furthermore, our preliminary data indicate that hepcidin-mediated iron restriction can not only ameliorate iron overload in β-thalassemia intermedia mice but can improve their disordered erythropoiesis as well, by as yet unknown mechanisms. We will examine the effects of hepcidin agonists on β-thalassemic erythropoiesis in mouse models and in bone marrow cultures and identify those mechanisms that could ameliorate anemia. Specific Aims 1. Select a parenteral and an oral minihepcidin for subsequent studies based on the dose-response relationship and duration of hypoferremic effect in C57BL/6 mice and hepcidin knockout mice. 2. Define the effects of minihepcidins in animal models of hereditary hemochromatosis. a. Can minihepcidins started after weaning prevent the development of iron overload in mouse models of severe (hepcidin knockout) or moderate (HFE knockout) hereditary hemochromatosis? b. Can minihepcidin treatment of mice with established iron overload (hepcidin or HFE knockouts) redistribute iron away from vulnerable cells and tissues (hepatocytes, pancreatic islet cells, cardiomyocytes) to relatively iron-resistant macrophages? c. Can minihepcidins reverse iron overload-related liver damage in the gerbil model of iron-induced hepatic cirrhosis? 3. Define the effects of minihepcidins in animal models of β-thalassemia. a. Can minihepcidins prevent iron overload in a mouse model of β-thalassemia intermedia, while improving (or not worsening) anemia? b. Can minihepcidins ameliorate iron overload in transfused mice with β-thalassemia major and redistribute iron to less vulnerable locations, without worsening anemia? c. Identify mechanisms by which minihepcidins can improve β-thalassemic erythropoiesis. Successful completion of this project would establish minihepcidins as viable drug leads for further development, most likely in the industrial setting, and would eventually help patients with iron overload disorders by providing them with improved therapeutic options.